Biomarkers, social, and affective predictors of suicidal thoughts and behaviors in adolescents

DESCRIPTION (provided by applicant): One third to one half of psychiatrically hospitalized youth is readmitted, with highest readmission risk 15-30 days post discharge and more than 80% readmitted within three months. The proposed study involves in vivo characterization of naturalistic phenomena associated with suicide risk after discharge adolescents using ecological methods and devices that allow acoustic capture of an individual's social environment and self-reports of experienced affect. We propose that social context and experienced affect are reciprocally reinforcing and that a reactive style involving close coupling of stressful social context (isolation, conflictual or high affect interactions) with affect reactivity (rapidly changig, intense affect, with slow return to baseline) increases risk for suicidal thoughts and behaviors. We also examine childhood maltreatment and epigenetic markers as predictors of post-discharge reactivity. Two hundred youth hospitalized for suicidal thoughts and behaviors will be followed prospectively using ecological methods and devices for three weeks following psychiatric discharge; suicidal thoughts and behaviors will be reassessed at 6 months. The present study further innovates through the incorporation of affect reactivity biomarkers (in-hospital blood samples for assessment of DNA/DNAm/expression). The proposed study merges multiple fields of study and permits an innovative and thorough characterization of the real-world interplay of affect and social context. Results of this investigation will inform a number of intervention approaches including family therapy, EMA-based adjunctive intervention, and pharmacological approaches.

Public health relevance
PUBLIC HEALTH RELEVANCE: Adolescents hospitalized for suicidal thoughts and behaviors are at high risk for rehospitalization and suicide attempts during initial weeks following discharge. The present study involves a rich characterization of adolescents' emotions and social interactions in the weeks following psychiatric hospitalization discharge using the combination of self-reporting on mobile devices and audio capture of social environment. The study also examines the ways that early life maltreatment may impact the emotional and social processes experienced by discharged adolescents.